IL1β Promotes Atheroprotective Changes in Late Stage Atherosclerotic Lesions

PROJECT SUMMARY: Complications resulting from rupture of unstable atherosclerotic lesions, including myocardial infarction and stroke, are the leading cause of death worldwide. Despite decades of research, the mechanisms and factors leading to plaque rupture remain poorly understood. It is generally accepted that lesions with a high smooth muscle cell (SMC) to macrophage (MΦ) ratio are less likely to rupture. However in the setting of atherosclerosis, SMC down-regulate their characteristic markers and express markers of other cells types and thus are undetectable using traditional markers. Indeed, rigorous SMC lineage tracing studies by our lab using Myh11 ERT2Cre eYFP ApoE-/- mice have shown that >80% of SMC within lesions lack expression of the markers previously used for their identification and that nearly 30% of these cells have activated multiple markers of MΦ. Therefore, the number of SMC within lesions has not only been grossly underestimated, but many cells thought to be MΦ are actually SMC-derived. Of even greater significance, we showed that SMC-specific conditional knockout of the stem cell pluripotency genes Klf4 and Oct4 had a profound impact on the pathogenesis of lesions including alterations in multiple indices of plaque stability. However, contrary to the dogma that SMC are always atheroprotective, we showed they can be either atheroprotective or -promoting depending on the nature of their phenotypic transitions. Taken together, studies highlight the importance of identifying factors and mechanisms that promote beneficial changes in SMC phenotype. An ongoing clinical trial is investigating neutralization of interleukin-1β in high-risk cardiovascular patients. The overarching hypothesis is that inflammation drives atherosclerosis, and that inhibition of inflammation will improve patient survival. However, there is a lack of preclinical evidence that neutralization of IL1β will confer beneficial effects in the setting of advanced atherosclerosis. Indeed, recent studies from our lab, which included the applicant, showed that treatment of our Myh11 ERT2Cre eYFP ApoE-/- mice with the Novartis IL1β-neutralizing antibody after the establishment of advanced atherosclerosis resulted in multiple changes consistent with reduced plaque stability including marked reductions in the number of SMC-derived eYFP+ cells within the fibrous cap, and replacement of these cells with MΦ. Studies in this proposal will test the hypothesis that IL1β signaling in SMC is critical for maintenance of plaque stability in late-stage atherosclerosis. Aim 1 test the hypothesis that the detrimental effects of anti-IL1β Ab treatment on late-stage atherosclerosis are primarily mediated through IL1R1 signaling in SMC and that this results in deleterious phenotypic transitions in lesion SMC. Aim 2 will test the hypothesis that increased production of interleukin-4 (IL4) following anti-IL1β Ab treatment of Myh11 ERT2Cre eYFP ApoE-/- mice with advanced lesions contributes to the deleterious effects of anti-IL1β Ab treatment on late-stage lesion pathogenesis observed in our initial studies. These studies will greatly increase our understanding of IL1β signaling in late-stage atherosclerosis and may identify approaches to augment current therapies to promote atheroprotective changes in SMC phenotypes and ultimately improve patient outcomes.

Public health relevance
PROJECT NARRATIVE: An ongoing large Phase III clinical trial seeks to reduce end stage cardiovascular events including rupture of atherosclerotic plaques that can trigger a fatal heart attack or stroke by treatment with an antibody that neutralizes the pro-inflammatory cytokine, interleukin-1 (IL1). However, recent studies from our lab using a unique mouse model of advanced atherosclerosis that allows us to rigorously assess the pathogenesis of lesions, have shown that inhibiting inflammation by targeting IL1 leads to unexpected undesired changes in lesions that would cause decreased rather than increased plaque stability. This research proposal will define mechanisms whereby inhibition of IL1 signaling results in destabilization of plaques with the long-term goal of identifying alternative therapeutic strategies that would promote beneficial changes in lesion stability in late-stage atherosclerosis and thereby reduce fatal end stage cardiovascular events.